Optically Gated Discovery of Protein-Biomolecule Interactions

The overall goal of research in the Geri lab is to map protein interactomes using discovery technologies that
provide orders of magnitude improvements in spatiotemporal resolution over the current state-of-the-art. The
motivation for this work is that advancing the resolution of protein interactome discovery technology beyond key
milestones, such as single cell and single protein thresholds, will have a field-wide impact analogous to similar
advances in transcriptomics and microscopy. The first three years of work in the lab will be focused on creating
new technologies by combining photocatalytic proximity labeling, in which light-powered catalysts attached to an
affinity handle drive the crosslinking of synthetic affinity probes with nearby proteins, with patterned light and
interaction-gated activation to simultaneously enforce multiple dimensions of specificity. The fourth and fifth
years of work will focus on applying the mature technologies. The overall strategy is divided along two thrusts,
in which labeling specificity is obtained through extrinsic optical control or intrinsic chemical control, and has
been designed to be programmatically robust by minimizing project interdependency. Intrinsically selective
systems will exploit the high spatial resolution of photocatalytic labeling (5 nm) and use “split” systems that
operate when defined protein targets are in proximity. Initial work will use natively expressed orphan peptides as
proximity labeling loci to discover their currently unknown receptors. The effort will cover thousands of peptides
by using label free ion mobility mass spectrometry for proteomics, maximally leveraged by using optimized
labeling probe designs. Split systems will combine multiple photocatalysts targeted to different proteins of interest
to make colocalization a dimension of specificity, and will be initially applied to map proteins present at membrane
junctions. Extrinsically controlled systems will enable subcellular resolution labeling in human tissue sections
and ms-resolution temporal control for the study of transient protein interactions. Both approaches are enabled
by combining optical tools for spatiotemporal control of light itself with the total and instantaneously responsive
(<1µs) dependence between photocatalytic efficiency and the local supply of light, and each allow for a three
order of magnitude increase in resolution vs current tools. Spatially selective labeling will focus on identifying
protein interactions unique to cell subpopulations in human tissues, with initial studies focusing on discovering
location-conditional interactions driving lymphocyte function in human tonsil and thymus. Later studies will focus
on discovering interactome differences between translationally relevant tissue samples. Temporally resolved
labeling will combine optogenetic tools and photocatalytic proximity labeling to synchronize and interrogate
transient protein interactions. The power of this approach will be fully exploited by studying exocytosis in neurons
with millisecond resolution, one of the fastest dynamic biological processes known. Successful development and
deployment of these systems for protein interaction discovery will enable the study of large interactome spaces
for the first time, and is expected to have a broad impact on the molecular biology community.

Public health relevance
Narrative Mapping networks of protein interactions is central to discovering the mechanisms of disease. This work aims to dramatically improve the specificity and power of technologies for protein interaction discovery, and then apply those methods to explore avenues of research in cancer, neurology, and immunology aimed at establishing new targets for drug development. The data generated through these studies, and also the broader application of these powerful tools, are therefore expected to lead to the development of new therapeutic and diagnostic approaches which will improve human health.